CAI2R Administration

Administration Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring
together collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. Technology Research and
Development (TR&D) Our administrative component supports this mission by a) maintaining efficient and
effective day-to-day operations, b) promoting robust communication among our staff and our various
stakeholders, and c) providing thoughtful strategic guidance informed both by external expertise and by
ongoing self-evaluation.